Isotopic Tracing of Sources and Cycling of Hazardous Metal Mixtures

Project 2 Summary
Native American communities surveyed in the Strong Heart Study (SHS) show markedly higher arsenic (As),
uranium (U) and selenium (Se) concentrations in urine relative to the average US population. Much of the
exposure to hazardous metal mixtures comes from drinking groundwater contaminated with metals often above
safety standards. Tribal lands in the US often coincide with mineral deposits, U mining, and metal(loid)
contamination in aquifers. In the Northern Plains, elevated concentrations of U and As in drinking water reflect
naturally occurring enrichment in aquifers, as well as the legacy of mining near tribal communities. Project 2 of
the Columbia University Northern Plains Superfund Research Program (CUNP-SRP) will use isotopic
compositions of U and Se, as these elements are sensitive to redox changes in the aquifer, to infer sources and
processes controlling contaminant exposures. Redox chemistry of U and Se controls their aqueous
concentrations in groundwater; the oxidized species are mobile and toxic whereas the reduced species are
insoluble. Concentrations of dissolved U and Se are affected by multiple processes (e.g., dilution, adsorption,
dispersion) and are poor indicators of redox-induced fate and cycling in groundwater. Thus, isotope ratios of
dissolved U and Se in groundwater, in tandem with concentrations, are invaluable for studying redox-induced
(im)mobilization, and tracing uptake and human exposure. We will use U and Se isotope ratios to characterize
redox reactions in groundwater, acquiring unique mechanistic information about the reaction progress. These
data will help us define local and more distal sources, and the transport and cycling processes of metals in
groundwater within the SHS communities in North/South Dakota. Furthermore, we will develop isotopic tracers
of U and Se cycling in humans impacted by environmental exposures. The specific aims are to: (1) Determine
spatial distribution pattern of isotope ratios or “isoscapes” of U and Se in groundwater samples. This will use
high-resolution data and models from Project 1 to target wells within and around U, As and Se hotspots for
isotopic characterization. We will also identify local versus distal sources of contamination around these hotspots.
(2) Determine the levels of naturally occurring reductive U and Se removal from groundwater and identify
conditions for potential As release based on the temporal evolution of U and Se isotope ratios. We will
characterize the redox transformation of U and Se and potential mixing of multiple groundwater sources (if any).
(3) Determine human exposure from the environmental contamination using isotopic tracers. We will develop a
novel non-invasive method to track metal exposure from U and Se in drinking water. For this, we will measure U
and Se isotope ratios in urine to constrain primary exposure sources and affected populations by linking those
to water isoscapes and the observational data from Project 3. Our results will help evaluate risk of exposure to
hazardous metal mixtures, monitoring and management of contaminated aquifers, and linking exposures to
environmental sources using a non-invasive diagnostic tool.

Public health relevance
Project 2 Narrative Project 2 of the Columbia University Northern Plains Superfund Research Program (CUNP-SRP) will develop the spatial and temporal distribution of uranium and selenium isotope ratios or “isoscapes,” from private groundwater wells, which will reveal the sources and mechanisms of hazardous metal cycling in the aquifers, and the evolution of existing uranium and selenium plumes. This study will also develop the use of isotope ratios as novel biomarkers of uranium and selenium exposure in humans linked to an environmental source. Our results will reduce risk from contamination, support monitoring and management of contaminated aquifers, and identify exposures using a non-invasive diagnostic tool for Native Americans.